Prolactin receptor signaling regulates adaptation of the heart during pregnancy and postpartum

The heart must continually adapt to a multitude of stimuli and stressors, which are generally divided into
pathologic and physiologic categories. Amongst these, the physiologic stress of pregnancy and its aftermath
(i.e., the postpartum period of lactation and nursing) are relatively less well understood, and much is unknown
about how extra-cardiac signals regulate and coordinate these processes. In a number of diverse maternal
tissues, including mammary glands, adipose and pancreatic β-cells, lactogenic hormones, acting via the prolactin
receptor (PRLR), activate downstream signal transduction and transcriptional regulation machinery to
orchestrate target tissue activity during pregnancy and regression following parturition and nursing. To date,
PRLR signaling in the heart during pregnancy has not been studied. The objective of this grant is to establish a
role for PRLR in adaptation of the heart to pregnancy and the reversal of gestational changes in the postpartum.
We explore the central hypothesis that cardiomyocyte lactogenic signaling, via PRLR, is essential for cardiac
adaptation. We will investigate novel physiologic roles of cardiomyocyte lactogenic signaling in two Specific
Aims. In Aim 1, we will establish the requirement for cardiomyocyte PRLR signaling in the adaptation of the heart
during pregnancy. Similarly, in Aim 2, we will identify a role of cardiomyocyte PRLR signaling in the postpartum
reversal of adaptive gestational changes in the heart, during the nursing period when the mother is lactating. To
do so, we employ a novel and unique genetic mouse model harboring a cardiomyocyte-specific deletion of PRLR
(CM-PRLRKO mice). We examine CM-PRLRKO mice using multiple analyses, including functional
(echocardiography), molecular (gene and protein expression), cellular (histologic), and metabolic (radiolabeled
isotope tracing) studies. Together, these studies will demonstrate that PRLR is required for normal gestational
cardiac remodeling, as well as for the cardioprotective benefits of lactation and breastfeeding, such that absence
of PRLR signaling or failure to nurse and lactate will have adverse effects on cardiac function and remodeling.
This research is significant because these studies would be the first to establish a physiologic role for PRLR
signaling in the adaptive responses of the maternal heart. At a fundamental level, these studies would expand
our understanding of the context and molecular mechanisms by which hormones regulate cardiomyocyte
function, and may identify novel pathways by which the heart restores itself following acute physiologic stressors.

Public health relevance
Pregnancy requires adaptation by many maternal organs, including the heart, but precisely how the heart responds to the dynamic changes of pregnancy and the postpartum periods is poorly understood. Here, we present novel data suggesting that prolactin receptor (PRLR) signaling is critical for the normal response of the heart to the physiologic stress of pregnancy, and resolution of those adaptations in the postpartum. Understanding the molecular mechanisms underlying adaptations driven by cardiac PRLR signaling will reveal novel insights into the biology of the heart during pregnancy and may predict novel targets to improve heart function during pregnancy in health and disease.